ENHANCEMENT OF BBB CROSSING OF AR DEGRADERS IN GBM

Abstract
Glioblastoma (GBM) is the most malignant brain tumor with poor prognosis. Very few patients could
survive more than a year after the diagnosis even with the development of new surgical techniques, which is
primarily due to the highly infiltrative/invasive behavior of these tumors. GBM commonly has de novo or
acquired resistance to Temozolomide (TMZ), a DNA-alkylating reagent that is the only chemotherapy for GBM
due to the excellent blood-brain barrier (BBB) penetration efficiency of 20%. GBM has a higher rate in men
than women. Androgen Receptor (AR) overexpressing contributes to this sex difference of GBM. AR is a client
protein of the 27 kDa Heat Shock Protein (HSP27) that plays a key role of AR stability and translocation into
cell nucleus. We hypothesize that AR-HSP27 axis is a critical driving force to tumor growth in GBM,
particularly for the male GBM patients. The proposed studies arise from our efforts to develop small molecule
AR degraders in GBM, which is a new approach for the treatment of GBM. We have identified a small
molecule AR degrader with an excellent BBB penetration efficiency of 30% that is better than TMZ. It also
selectively inhibited AR overexpressed GBM cell growth. We propose to systematically investigate the in vivo
activity of the drug candidate and its combination with TMZ in GBM models including cells from patients, and
further structurally optimize the lead compound.
Aim 1: Structurally optimize AR degrader and evaluate the in vitro biological activity with GBM cells.
We will: a) Synthesize new analogs; evaluate the compounds for the growth inhibition to AR
overexpressed GBM cells; b) Determine the activity of top derivatives on cellular AR protein degradation
through western blotting assays; examine the HSP27 targeting effects using the HSP27 chaperone and
surface plasmon resonance (SPR) assays. c) Measure the Log P value of the new analogs to identify
candidates with better BBB penetration.
Aim 2: Determine the pharmacokinetic (PK) profile, examine the in vivo activity of the drug candidates
with mice GBM models.
We will: a) Determine the PK profiles of the new lead compound and TMZ for their co-administration to
mice. Examine the in vivo anti-tumor activity of the combination with patient derived xenograft (PDX) GBM
models including subcutaneous and intracranial tumor. b) Determine the PK profile and in vivo activity of the
new candidates identified in Aim1 and their combination with TMZ.

Public health relevance
Public Health Relevance Overexpression of the Androgen Receptor (AR) is known to promote invasion and progression of glioblastoma (GBM), contributing to a higher disease rate in males compared to females. Targeting AR for degradation could disrupt this signaling pathway and selectively inhibit the growth of AR-overexpressing GBM. Unfortunately, there are currently no drugs capable of inducing AR degradation that can penetrate the blood-brain barrier (BBB). Our proposal aims to develop a small molecule AR degrader based on a lead compound from our lab. The approximately 60 newly designed derivatives in this project have been specifically crafted to possess the necessary characteristics to effectively pass through the BBB for the treatment of GBM. We anticipate that our systematic investigation into the in vivo activity of the current identified drug candidate, as well as the discovery of even more potent derivatives, will significantly impact the treatment of AR-overexpressed GBM through a novel mechanism. This project holds immense potential for the development of new drugs targeting AR-overexpressing GBM, offering hope for improved outcomes for patients with this devastating disease.